Core D: Flow Cytometry

Project Summary/Abstract
CORE D- The Flow Cytometry (FC) Core is a centralized, shared resource that significantly enhances the
research capabilities of HIV investigators. In addition to providing solid support to the funded projects of
established investigators, a primary objective of the FC Core is to provide the scientific environment and
material resources to enable emerging investigators to apply flow cytometry technology to their developmental
projects and to encourage established investigators to initiate innovative pilot or collaborative studies. To
sustain this goal, the Core will pursue three main specific aims: 1) provide a stable, centralized resource of
technical expertise and major instrumentation; 2) enable, promote, and enhance multidisciplinary HIV
research; and 3) train, mentor and promote career development of emerging investigators.
Aim 1 will be achieved by: maintaining a range of services for cell analysis and sorting; offering expert
consultation and training in study design, optimal method applications and data interpretation; making state-of-
the-art instrumentation accessible through highly skilled technician operators and an established recharge
mechanism; creating economies of scale to support operations; and ensuring biosafety and data quality.
Aim 2 will be achieved by: providing a unique biocontainment cell sorting facility; identifying innovative
technologies for transfer and application, and developing new methods; customizing experimental design and
data analysis to individual projects; advancing new opportunities in translational and clinical research; and
encouraging synergy and collaboration across CFAR cores and between diverse research groups.
Aim 3 will be achieved by: providing an interactive and supportive learning environment; teaching application of
flow cytometry technology to address important questions in HIV research; offering individualized constructive
feedback; and giving fiscal support to developmental and pilot research projects through provision of method
protocols, research reagents and instrument time.
To meet the research needs of our investigators, the FC Core facility offers the instrument services of three cell
analyzers (two 3-laser FACS Cantos; a 2-laser iCyte LSC) and two high-speed cell sorters (3-laser FACS Aria
II; 4-laser MoFlo XDP) to generate multi-parameter cell analyses (up to 12 colors, 14 parameters). Core
operations are guided by a senior faculty Director (23+ yrs experience) and a junior faculty Leadership Trainee.
Two full-time dedicated technician/operators, a lab manager (>18 yrs experience) and a licensed senior
technologist (>30 yrs), provide exceptional support that is consistently viewed as highly dependable by users.
To ensure services remain relevant, the Core undergoes a rigorous strategic planning process; and to
accommodate an increasing number of complex service requests, it steadily upgrades infrastructure capacity
and realigns technical support to meet shifts in user-initiated demands.